Plasticity of Type 3 Innate Lymphoid Cells Regulated by Intestinal Microenvironment

Project Summary/Abstract: (30 lines of text maximum)
Innate lymphoid cells (ILC) are the innate counterparts of CD4+ T helper cells and are particularly abundant in
mucosal tissues where they contribute to tissue immunosurveillance, immunoregulation, tissue repair, and the
maintenance of homeostasis or tissue inflammation. Based on transcriptional regulation and cytokine profiles,
three distinct types of ILCs have been proposed and identified: T-bet+ ILC1s that produce IFNg, GATA3+ ILC2s
that secrete IL-5 and IL-13, and RORgt+ ILC3s that release IL-22 and IL-17A/F. However, ILC numbers and
functions are believed to vary in a context-dependent fashion such that single-cell RNA-Seq and flow cytometry-
based analyses including a range of markers have revealed high levels of ILC heterogeneity arising due to the
plasticity of these cell populations. However, the molecular mechanisms and environmental cues governing this
plasticity remain to be elucidated, in part due to a lack of appropriate animal models. We thus generated ILC3-
specific reporter and Cre recombinase-expressing mice in which we identified GATA3+ exILC3s which were
previously ILC3s but has converted into the ILC2s. Using this model, the goals of this study are to examine (1)
the mechanistic basis for transdifferentiation between ILC3s and ILC2s and (2) the roles that these plastic ILCs
play in vivo. To accomplish these goals, we have formulated two specific aims. In Aim 1, we seek to understand
the environmental factors and mechanisms that regulate the maintenance of ILC3 identity and plasticity. Using
ex vivo and in vivo models with fate mapping approaches, we will evaluate the environmental cues such as gut
inflammation and gut damage associated with transdifferentiation and will elucidate the physiological roles of
transdifferentiated cells during gut inflammation. By gathering phenotypic, transcriptomic, and chromatin
accessibility data, we will capture the functional status and transdifferentiation potential of cells with distinct
identities. While our supporting data clearly indicate that ILC3s can undergo conversion into ILC2s, when, where,
and how ILC3s actively convert into ILC2s remain to be established. In Aim 2, we thus propose to elucidate the
active conversion from ILC3s to ILC2s in response to tissue-specific factors under ILC2-intensive conditions
and/or when the identity of ILC3s is decreased. To do this, we will adapt our ILC3-fate mapping mice to models
of helminth infection and type 2 immunity-mediated colonic inflammation and will explore ILC3s conversion into
ILC2s. We will also clarify the roles of GATA3+ exILC3s under steady-state conditions and in inflammatory
settings. Through the conditional deletion of GATA3 only in the converted ILC2s from ILC3s or the reconstitution
of ILC2-depleted mice with GATA3+ exILC3s or naturally generated ILC2s derived from their precursors in the
bone marrow, we will interrogate their roles during helminth infection and type 2 immunity-mediated inflammation
in the colon. These studies will advance our current understanding of ILC plasticity under specific circumstances.
The insight gained from these analyses will better enable us to control the balance among ILCs in vivo, leveraging
such plasticity under ILC-intensive settings of infection, inflammation, and the repair of intestinal damage.

Public health relevance
Project Narrative (2-3 sentences): Under conditions of acute or chronic inflammation caused by infections or various inflammatory diseases including inflammatory bowel diseases, many immune cell subtypes are activated and may expand or become dysregulated, thereby contributing the pathogenic tissue damage. Although plasticity in immune cells like T cells and innate lymphoid cells (ILCs) affords these cells the flexibility to facilitate both tissue inflammation and repair based on the context-dependent regulation of T cell and ILC functions, the underlying mechanisms governing the plasticity of ILCs have not yet been well characterized. In this proposal, we plan to investigate the mechanistic basis for the transdifferentiation of ILCs in response to infection, acute inflammation, or chronic gut inflammation with a specific focus on the roles that these plastic ILCs play in vivo and on the conversion between ILC2s and ILC3s such that these results may offer new insight into how best to control ILC responses under conditions of ILC2- or ILC3-intensive tissue inflammation such as IBD.